Mechanical Regulation of Actin Binding Proteins

Project Summary
PI: Daniel Fletcher, Ph.D.
NIH R01 Administrative Supplement
Project Title: Mechanical Regulation of Actin Binding Proteins
Project Period: 7/25/2019 – 4/30/2023
The actin cytoskeleton consists of spatially organized structures of filaments that are architecturally distinct and
formed from over 300 different actin-binding proteins. One of the key roles of actin networks in cells is to
generate, transmit, and resist physical forces, but whether the forces carried by actin filaments influence the
binding of actin-binding proteins is not well understood. This project is investigating the ability of tandem calponin-
homology domains (CH1-CH2) to bind actin filaments in a tension-dependent manner, and it will explore the
functional impact of tension-dependent binding through a set of in vitro and live cell experiments. The requested
FRET-FLIM attachment will provide a way to test our hypothesis that tension-dependent changes in actin
filaments can alter protein binding affinity by relieving the steric inhibition at the binding interface. The outcome
of this work will be a new understanding of how force can organize actin networks and influence the function of
both healthy and diseased cells.

Public health relevance
Project Narrative PI: Daniel Fletcher, Ph.D. NIH R01 Administrative Supplement Project Title: Mechanical Regulation of Actin Binding Proteins Project Period: 7/25/2019 – 4/30/2023 A primary role of the actin cytoskeleton is to generates and transmit forces through cells, but it is unclear whether forces on filaments could affect the localization of the myriad actin-binding proteins in cells. Here we test the ability of the most common actin-binding domain to bind actin filaments in a tension-dependent manner and explore the effects of tension-dependent actin-binding proteins on cell migration. The requested FRET-FLIM attachment will enable direct measurement of tension-dependent binding to mechanically loaded filaments.